Interrogating laboratory-adapted strains of Bacillus subtilis to elucidate the selective pressures of laboratory conditions on multicellular bacterial behaviors

Abstract
Bacteria carry out a variety of multicellular processes that influence their pathogenesis and environmental roles
in the natural environment. However, it has become apparent that when these organisms are studied in the
laboratory, they undergo significant genetic modification over time. The long-term goal of this project is to
understand how the laboratory environment itself selects against and/or changes the fitness effects of
multicellular bacterial behaviors including biofilm formation, motility, and the secretion of pigmented secondary
metabolites. These features, however, are critical due to their influence on bacterial pathogenesis and their
positive or negative environmental effects. The PI will characterize laboratory adapted strains of B. subtilis
isolated from populations that grew in the common laboratory medium LB for approximately 300 generations.
These strains have distinctive changes in motility, biofilm formation, and pigment production. The goals of this
project are to use these laboratory-adapted strains to: 1) Identify the molecular mechanism(s) that causes an
unusual “social swimming” behavior in one laboratory adapted strain, as surprisingly, this strain actively forms
large, multicellular aggregates in broth culture. 2) Quantify the costs and benefits of motility in laboratory culture,
as preliminary data suggest many laboratory-adapted strains have reduced or altered motility. 3) Identify the
pigments produced by a laboratory-adapted strain and the wildtype B. subtilis strain NCIB3610 under distinct
laboratory conditions, and quantify the effects of the production of these pigments on fitness in the laboratory. 4)
Identify the environmental and metabolic pathways responsible for the triggering of production of pigmented
natural products by Bacillus subtilis, focusing on pulcherrimin; and determine the relationship between pigment
production and biofilm formation. This research is innovative because social swimming is a novel phenotype that
could inform understanding of the evolution of multicellularity. Also, preliminary data identify discrepancies
between our observations and the current model explaining the role of the pigment pulcherrimin in Bacillus
subtilis, suggesting that additional research on the role of this pigment in B. subtilis is needed. This is important
due to the role of pulcherrimin in biofilm formation and its antimicrobial properties. Additionally, this work will
provide insights to scientists studying multicellular processes like motility in the laboratory, as this work will
identify probable effects of the laboratory environment itself. Furthermore, this proposed project will enhance the
research environment at Siena College significantly by providing support to involve more undergraduate students
in research, increasing research capacity, and due to Siena’s student population, will aid in the larger goal of
increasing diversity in STEM.

Public health relevance
Bacteria in the terrestrial environment and in the human body face stiff competition for scarce resources. Motility systems, metal scavenging and binding systems, and the ability to form multicellular structures each contribute to a strain or species’ competitiveness. Characterization of bacterial strains that were experimentally adapted to the laboratory environment can help identify genetic and molecular processes that give specific organisms a competitive advantage, which can improve understanding and hopefully allow intentional alterations of microbial growth patterns in a variety of microbial contexts including human infection.